The Indiana University-Ohio State University Maternal and Pediatric Precision in Therapeutics Data, Model, Knowledge, and Research Coordination Center (IU-OSU MPRINT DMKRCC)

Summary (Overall)
The Maternal and Pediatric Precision in Therapeutics (MPRINT) Hub will serve as a national resource for multi-
disciplinary expertise and knowledge in maternal and pediatric therapeutics. The MPRINT Data, Model,
Knowledge, and Research Coordination Center (DMKRCC) will support the MPRINT Centers of Excellence in
Therapeutics (CET) and Steering Committee to coordinate and expand research relating to maternal and
pediatric therapeutics. The DMKRCC will serve as the administrative component of the MPRINT Hub, coordinate
outreach and dissemination of MPRINT Hub activities, and will serve as a conduit between the MPRINT Hub
and the broader scientific community. Additionally, the MPRINT DMKRCC will organize annual MPRINT
meetings and educational activities, including webinars, to cultivate translational research in maternal and
pediatric therapeutics. The DMKRCC will identify, aggregate, and make available data, knowledge, and expertise
in maternal and pediatric therapeutics to the wider research, drug development, and regulatory communities.
Specifically, the DMKRCC will identify, evaluate, and collate pertinent data in a knowledgebase that will be made
available through a web portal; utilize and enhance pharmacometric modeling approaches such as
physiologically based pharmacokinetic and pharmacodynamic (PBPK/PD); support clinical trial design; and
foster expertise in drug development and personalized therapy for maternal and pediatric populations. The
specific aims of this proposal will develop a cohesive organizational structure to support the research of the
MPRINT Hub as a whole as well as the individual cores within the DMKRCC. We will develop infrastructure to
facilitate data sharing and knowledge dissemination, and work with the CETs and Steering Committee to identify
and address changing needs of the maternal and pediatric communities.

Public health relevance
Project Narrative Women and children were historically excluded from and continue to be under-represented in clinical research studies, leading to a paucity of knowledge relating to pharmacokinetics and pharmacodynamics of therapeutic agents in these populations. The IU-OSU MPRINT DMKRCC will identify data relevant to understanding maternal and pediatric physiology, pharmacology, and clinical outcomes from literature, public resources, and MPRINT collaborators, integrate data into pharmacometric models to enhance knowledge and understanding of drug disposition and response, and support drug development and therapeutics in maternal and pediatric populations. The ultimate goal of this proposal is to enhance drug safety and efficacy in maternal and pediatric patients by understanding inter- and intra-individual sources of variability.